Identifying interconnections of the disparities in childhood obesity

PROJECT SUMMARY/ABSTRACT:
Childhood obesity is a serious concern, particularly in low literacy and low-income populations among
minority children. Obese children are at higher risk of developing type 2 diabetes, cardiovascular disease, cancer,
asthma, and worse coronavirus disease 2019 (COVID-19) outcomes. Around 36% of children live in poverty,
and 42% live in low-income families. There are also racial and ethnic disparities in parent education. 40.4% of
non-Hispanic white children have a college-educated parent, compared with 20.3% of non-Hispanic black. The
rate of obesity in African Americans is 24.2%, and in whites is at 16.1%. African American adults are found to
have high oxidative stress than Caucasians. Several volatile organic compounds (VOCs) are generated by the
reactive oxygen species. However, there is significant gap in the research directly examining the association of
racial disparities with oxidative stress and VOCs.
The overall objective of this study is to determine the association of urinary oxidative stress, volatile
organic compounds profile, and oxidative stress-derived VOC metabolites with race/ethnicity and childhood
obesity. We plan to accomplish the objective of this application by pursuing the following specific aims. (1)
Determine the urinary oxidative stress, VOC metabolites, and oxidative stress-derived VOCs associated with
race/ethnic disparity in childhood obesity. (2) Determine if oxidative stress induces the release of VOC
metabolites.
This research will fundamentally advance our understanding of the association between oxidative stress
and the volatile organic compound metabolites with the disparities in childhood obesity. The findings will help
reveal the early metabolic non-invasive biomarkers of disparities in childhood obesity. We strongly believe that
the direct research experience gained by the undergraduate and graduate students working on this project will
help them understand the pathophysiology associated with the disparities in childhood obesity. The successful
completion of the study will help the involved students to gain in-depth knowledge of disparities and prepare
future scientists to pursue their careers in health-related disciplines.

Public health relevance
PROJECT NARRATIVE: The prevalence of childhood obesity varies widely among race/ethnicity with higher rates in African Americans making it one of the most profound health disparities. This study will focus on identifying the association of urinary oxidative stress, volatile organic compounds profile, and oxidative stress-derived volatile organic compound metabolites with race/ethnicity and childhood obesity. The findings will help to identify the early metabolic non- invasive biomarkers of disparities in childhood obesity.